A RESEARCH STUDY INVESTIGATING THE EFFECTS OF PARTIAL PANCREATECTOMY ON GLUCOSE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. To establish the impact of a deficit in beta cell mass due to partial pancreatectomy on glucose tolerance (Fasting glucose measurement, oral glucose tolerance testing)